Synergistic gut-brain axis modulation via vagal stimulation and cognitive behavioral therapy in functional dyspepsia

PROJECT SUMMARY/ABSTRACT
Functional dyspepsia (FD) is one of the most common disorders of gut-brain interaction (DGBI), characterized
by recurrent epigastric discomfort consisting of any one or a combination of postprandial fullness, early
satiation, and/or epigastric pain or burning, in the absence of a clear structural etiology. Despite the high
prevalence, there is a lack of treatment options available to patients for whom traditional pharmacological
interventions have failed due to either lack of efficacy or uncontrollable side effects. While many non-
pharmacological therapies have shown promise for DGBI, including FD, the efficacy of any single-modality
treatment is typically modest. Finding a way to boost clinical outcomes for these therapeutic modalities is a
crucially important goal. As FD is a multifactorial condition with visceral, affective, and cognitive components,
we propose that multimodal neurophysiologically-informed strategies – e.g. combining bottom-up and top-down
approaches - will enhance benefits by targeting different, but convergent, neural pathways that contribute to
FD symptomatology. To date, however, better integration of bottom-up and top-down strategies has been
hampered by a lack of mechanistic understanding of how they interact to improve FD symptoms, presenting a
knowledge gap that, when filled, could help optimize care by illuminating approaches that are most likely to
have a synergistic salubrious effect. Specifically, we propose a randomized, single-blinded, 2x2 sham-
controlled trial to investigate the potential synergy of transcutaneous auricular vagus nerve stimulation (taVNS,
bottom-up) with GI-targeted cognitive-behavioral therapy (GI-CBT, top-down). We will evaluate the longitudinal
effects (8 weeks) of taVNS+CBT (or controls) on post-meal gut-brain physiology and clinical outcomes.
Furthermore, we will examine the role of GI-specific anxiety in anticipating (i.e. change at 4 weeks) and thus
predicting clinical improvements following 8 weeks of therapy, as well as mediating post-therapy changes in
gut-brain physiology and clinical outcomes. In our study, we will exploit our fully non-invasive experimental
framework including sequential gastric and brain Magnetic Resonance Imaging (MRI). The significance of our
proposal is high as it will provide a mechanistic framework for how taVNS and CBT, both separately and
synergistically, modulate FD pathophysiology, leading to future clinical trials to evaluate this integrated
multimodal intervention for difficult to treat chronic GI disorders, such as FD.

Public health relevance
PROJECT NARRATIVE The primary aims of this randomized, single-blinded, 2x2 sham-controlled trial are to 1) evaluate synergistic impact of 8-weeks of transcutaneous auricular vagus nerve stimulation (taVNS) + cognitive-behavioral therapy (CBT) on post-meal gut-brain communication; 2) determine the sequential relationship between treatment- associated changes in GI-related anxiety and both clinical functional dyspepsia (FD) improvements and meal- induced physiological outcomes; 3) investigate whether post-treatment changes in gut-brain physiology mediate improvements in FD clinical outcomes. Using our fully non-invasive framework including gastric and brain MRI and taVNS, we aim to evaluate the potential synergy of taVNS and CBT in FD, by assessing the gut-brain physiological response to prandial challenge, linking physiological with symptom improvements.